Administrative Core

Project Summary
The key objective of the Administrative Core is to enhance the overall productivity of the Program through
administrative synchronization. The organization and activities of the Administrative Core will focus on
monitoring progress and providing a link for the 3 Research Projects so that productive collaboration and vital
integration of discoveries are realized. The Core will establish a solid connection of all the components to make
them more effective, to facilitate interactions and communication with each other, to reduce administrative
burdens for the Projects and Science Core, and to encourage bidirectional connections with the broader
research community. The Core will achieve this by providing essential administrative and fiscal support for the
entire Program Project. Administrative support responsibilities will include providing the Program Director,
individual Project leaders and Scientific Core Director with secretarial and research administration support;
scheduling of Project Leaders and Core Directors meetings, lab meetings, and External and Internal Advisory
Board meetings; travel arrangements for Program staff and External Advisory Board members; organizing
annual retreats; assisting with manuscript preparation; recordkeeping and correspondence. Fiscal support will
include the monitoring of expenditures and account activities to ensure compliance with BCH and NHLBI
policies and regulations; serving as the main contact for relevant sub-contract billing, for invoice processing
and for negotiating with outside vendors. Through the management of the majority of general administrative
tasks, compliance issues, and financial issues in the Program, the Administrative Core will help to facilitate the
Program’s success in attaining its programmatic goals.